COLLECTION OF MUTANT TYPES OF DROSOPHILA MELANOGASTER

To provide funding of the National science Foundation (NSF) ¿supported Living Stock collection entitled “Collection of Mutant Types of Drosophila melanogaster” or the Bloomington drosophila Stock Center. This is a model organism to investigate fundamental problems in biology, and developmental biology